Signaling dynamics in orchestrating stem cell functions during mammalian tissue regeneration

Summary
Normal tissue structure and function rely on the regenerative capacities of tissue resident stem cells.
These stem cells engage in essential activities like proliferation, migration, and differentiation, which must be
carefully coordinated through dynamic signaling interactions to ensure effective tissue regeneration. Disruption
of this process can give rise to diseases, including cancer. Thus, comprehending how dynamic signaling
activations orchestrate stem cell behaviors to regenerate tissue and sustain tissue function is of paramount
importance for advancements in regenerative medicine and cancer therapy.
The inability to simultaneously track the dynamic signaling changes and stem cell activities in most
mammalian tissues has been limiting our knowledge of the signaling mechanism of stem cell coordination. By
generating novel signal sensors and employing our intravital imaging approach on a tissue regeneration model,
the hair follicle, our previous studies have overcome this challenge and enable us to interrogate the functional
significance of signaling dynamics at the single-cell level in orchestrating regenerative cell behaviors.
Previous studies in culture systems and simple epithelial models have discovered regulatory roles of the
distinct signal dynamics for specific cell behaviors. It remains largely unclear how dynamic signaling activations
orchestrate diverse behaviors during complex tissue regeneration. Here, we study this question by using mouse
hair follicle regeneration as a model, which requires both epithelial and mesenchymal signals. We hypothesize
that stem cell behaviors are directly coordinated by epithelial ERK signal dynamics and indirectly influenced by
TGFβ-mediated mesenchymal organization. We will test this hypothesis by defining the dynamics of the epithelial
ERK (Aim 1) and mesenchymal TGFβ (Aim 2) signals and assessing the functional implications of those
dynamics on stem cell behaviors and functions. We will apply intravital imaging, genetic, optogenetic, and
pharmacological manipulations, as well as novel molecular analyses to gain new insights into the mechanisms
by which dynamic signals orchestrate different cell behaviors to support effective tissue regeneration and uphold
normal tissue architecture. The outcomes of the research will significantly advance our knowledge of the
signaling mechanisms that both promote and disrupt tissue regeneration, which will pave the way for the
development of innovative strategies to treat various diseases in the future.

Public health relevance
Narrative Our tissues rely on the teamwork of special cells called stem cells to stay healthy. The proposed research aims to use novel approaches to understand how stem cells work together to regenerate tissue and maintain normal tissue functions. The knowledge gained from this study will help us design novel strategies for treating diseases through regenerative medicine.